Case Studies In Genetics

During my career I have worked on several projects creating software (FASTLINK, CASPAR, rhtspmap,[unreadable] PedHunter, etc.) and a database (Anabaptist Genealogy database) for genetic studies.[unreadable] My association with this software and a past track record of effective collaboration[unreadable] with wet lab scientists leads to more and more such collaborations.[unreadable] Two highlights from the past year are:[unreadable] -- publication in the January 2007 issue of Nature Medicine of the characterization of[unreadable] a new hypopigmentationneutropenia syndrome and identification of its molecular[unreadable] cause as a mutation in the 3 untranslated region of the gene encoding p14.[unreadable] -- the completion of major improvements to our software rhtspmap for constructing radiation[unreadable] hybrid maps; the new version 3.0 was released and accompanied by a short paper in[unreadable] Bioinformatics describing the improvements.[unreadable] [unreadable] The immunodeficiency work is part of a longstanding collaboration with Dr. Bodo Grimbacher[unreadable] (formerly U. Freiburg, GERMANY, now University College London, UK) on genetics of[unreadable] human immunodeficiencies. Our work on neutropenia is led by Prof. Christoph Klein (Hannover [unreadable] Medical School, GERMANY). We are actively hunting genes for other human immunodeficiencies[unreadable] and also hunting more neutropenia genes.[unreadable] [unreadable] The work on rhtspmap is done in collaboration with Dr. Richa Agarwala (NCBI) and summer intern Edward Stallknecht Rice. We try to make the software general and robust enough that users can[unreadable] use it themselves, and some published maps have been constructed with rhtspmap, without our[unreadable] intervention. We have been collaborating with William Murphy (Texas A M) University on maps of the cat (Felis catus) and with Bhanu Chowhowdhary and Terje Raudsepp (also Texas A M) on maps of the horse (Equus caballus). During this past year we started collaborating with M. Elisabete J. Amaral (Sao Paulo University) and James Womack on maps of river buffalo (Bubalus bubalis). Several publications resulted from these collaborations including a paper in the February 2007 issue of Genomics presenting a new. denser map of the cat. This map was used by LGDNCI Frederick and their[unreadable] collaborators as a guide to making the first genome assembly of parts of the cat genome, which[unreadable] will be published in a future issue of Genome Research.